Novel gyrase inhibitors targeting Mycobacterium tuberculosis

PROJECT SUMMARY
This R21 project is designed to determine structure activity relationships (SARs) of a particular chemotype of
4-(1-methylimidazo[1,2-a]pyridine-1-ium (aka CPD229 and analogs), new antimycobacterial gyrase inhibitors
discovered in our recent HTS campaign targeting bacterial DNA gyrase funded by an NIAID grant
1R21AI125973. We will also improve their Mycobacterium tuberculosis (Mtb) whole cell potency and
pharmacological properties. Additionally, we will determine the mechanism of action (MoA) of these new
gyrase inhibitors both in vitro using purified Mtb gyrase and in vivo within Mtb. DNA gyrase, an essential
enzyme to Mtb, is an excellent and validated target for discovering and developing new antibiotics to treat
MDR-TB. Fluoroquinolones (FQs), one of the most important and prescribed antibiotics, target bacterial DNA
gyrase. FQs are widely used as anti-TB drugs, usually as the second-line antibiotics for MDR-TB patients.
However, FQ-resistant Mtb strains have been discovered threatening the utility of FQ for TB treatment. Certain
FQs also have serious side effects. These newly identified antimycobacterial gyrase inhibitors, structurally
distinct from FQs, provide promising starting points for development and optimization of novel antibiotics that
should yield effective therapeutics capable of overcoming FQ-resistance and effectively treating MDR-TB.
Success in these proposed studies would provide potent non-FQ antimycobacterial gyrase inhibitors for the
development of new antibiotics/therapy for the global public health problem of multi-drug resistant TB.

Public health relevance
PROJECT NARRATIVE Tuberculosis (TB), especially multi-drug resistant TB is a major global health problem and causes more than 1.5 million deaths annually. The worst scenario is that some multi-drug resistant TB patients have nonresponsive totally drug resistant Mycobacterium tuberculosis and cannot be treated by current multi- antibiotics regimen. This project seeks to combat this urgent public health threat by developing the hits from our recent high throughput screening campaign against bacterial DNA gyrase into new anti-TB antibiotics targeting Mtb gyrase.